The IL-23/IL-17 Axis in Inflammatory Arthritis

Project Summary/Abstract
About 50 million Americans (22%) suffer from some form of inflammatory arthritis and estimates are that, with
the aging population worldwide, 67 million adults will have arthritis by 2030 with an economic impact higher
than $128 billion dollars. Although interleukin-23 (IL-23) has been implicated in the pathogenesis of arthritis,
the molecular mechanisms remain unknown. Since the discovery of IL-23 regulation of pathogenic T helper
cells that express interleukin-17 (Th17) the importance of direct actions of IL-23 in arthritis is overshadowed.
To highlight its importance we developed gene-transfer models of IL-23 and IL-17A and using these models we
established that IL-23 is a potent inducer of arthritis, independently of IL-17A. Dissection of IL-23 from the IL-
23/IL-17A axis has allowed us to uncover novel mechanisms of myeloid cell activation previously overlooked.
We identified that IL-23 induces arthritis independently of Th17 cells and through activation of myeloid cells. T
cells and myeloid cells share a requirement for costimulatory signals that are mediated by ITAMs. The ITAM is
a conserved signalling motif contained in the cytoplasmic domain of transmembrane adaptor molecules that are
associated and transmit signals from various immunoreceptors present in haematopoietic progenitors. We have
identified that IL-23 induces the activation and recruitment of MDL-1 receptor that orchestrates synovial and
skin inflammation via the activation of osteoclasts and neutrophils respectively. Discovering the cellular and
molecular mechanisms that dictate recruitment and activation of osteoclasts in inflammatory arthritis is central
to preventing this disabling condition. Detailed understanding of these cellular and molecular interactions will
yield insights into regulation of arthritis that can be exploited for therapeutic interventions.

Public health relevance
Project Narrative In this project we investigate the role the IL-23/IL-17 axis in the activation of innate immunity and the modulation of cell differentiation programs leading to bone and skin pathology as commonly occurs in autoimmunity.